BITE (Bat Immunology Training and Education) - an undergraduate experiential program for developing the next generation of One Health scientists

Project Summary/Abstract
Without T cells (e.g., CD4+ helper, CD8+ cytotoxic), mammals cannot have a proper functioning immune
system or fight off viral infection. Classically, T cells in mammals develop in the thymus then migrate to
peripheral tissues and circulate in the blood. Development of T cells is critical for mounting antiviral response
cytokines, immune memory, regulation, pathogen recognition, activation of B-cells to produce antibodies, and
cytotoxic response to virus-infected cells. Bats are able to suppress the most highly pathogenic viruses found
in mammals (e.g., SARS, Ebola, Rabies, and Nipah) with little to no clinical symptoms or pathology acting as
the main reservoir. Yet after 100 years of anatomical study little is known about T cell development,
abundance, expression, or T-cell receptors (TCRs) repertoire within bats. Studies of bat T cell development
and responses in bats have largely been understudied due to lack of immunological reagents such as
antibodies specific for bats.
In this resubmission, our research team has provided preliminary data using x-ray computed
tomography, histology, and immunohistochemistry that bats have thymus with T cells present. We also provide
evidence of age related thymus involution within adult big brown bats (Eptesicus fuscus). In our proposal, we
will use museum voucher specimens and collect wild bats to further develop methods for structural and
molecular approaches to study lymphoid organs and T cell development.
Our team has decades of experience in mammalogy, viral-host interaction, adaptive immune system
sequencing (VDJseq), and viral immunology. We will provide ultrastructural determination of the bat’s thymus,
spleen, lymph ducts, and bone marrow that will include development of antibodies for flow cytometry/FACS or
mRNA based in situ hybridization flow cytometry (Flow-FISH), single molecule fluorescence mRNA in situ
hybridization (mRNA-smFISH) and immunohistochemistry (which we have preliminary data) that will elucidate
the lymphoid organs of T cell development (Aim 1). In Aim 2, we will assess T cell development in bat primary
and secondary lymphoid organs across developmental age (juveniles, subadults, and adults) and examine
sexual dimorphism, using bulk organ RNAseq, single cell RNAseq, and RT-ddPCR. Using VDJseq/TCRseq we
will measure the TCR repertoire diversity across lymphoid tissues and blood (Aim 2). In Aim 3, we will access
and link thymic involution to the susceptibility of bats to pathogenic viruses.
Our proposal and team is uniquely posed to provide a new path towards unraveling the ‘black box’ of
bat T cell adaptive immune responses. This is foundational work that will enable further immunological study in
bats and other small mammals but provide a groundwork to new immunotherapies, vaccines, antivirals, or
anti-inflammatory drugs.

Public health relevance
Project Narrative Our overall objective is to unravel T cell development throughout a bat's lifespan, leading to long-term viral suppression via adaptive immunity. Fundamentally, T cells arise from the bone marrow, they then migrate to thymus where they develop into naïve T cells, that circulate in peripheral tissues and blood - where they act as 'sentinels cells’ (e.g., CD4+ helper, CD8+ cytotoxic) that suppress viral infection. However, after 100 years of anatomical study in bats, the role of the thymus in T cell development has not been described, nor has how T cell development occurs in the thymus or other lymphoid organ, which is the fundamental tenet of T cell immunology.